EEPD1 Repair of Stressed Replication Forks

PROJECT SUMMARY
Since DNA bases are continuously damaged by oxidation, cells have evolved a robust pathway to repair this
type of DNA base damage, termed base excision repair (BER). Most oxidative damage can be repaired at the
cell’s leisure except at a replication fork, where oxidative damage can cause replication fork collapse.
Collapsed forks are a far greater danger to the cell than oxidative damage elsewhere in the genome, but the
mechanism of BER at oxidatively damaged replication forks is less well understood compared to BER
elsewhere. The 5’ abasic endonuclease APE1 plays a key role in BER repair at oxidatively stressed replication
forks. However, there is significant evidence for an alternative pathway; some cancers lack APE1 yet replicate
without difficulty, and several aging organs lose expression of APE1 without deleterious effects. We previously
found that the 5’ endonuclease EEPD1 can initiate homologous recombination (HR) repair of stressed
replication forks by cleaving the lagging parental strand of a stalled fork and loading EXO1 for 5’ end resection
in a BRCA1-indepednent manner. In further characterization of EEPD1, we found that it has 5’ abasic
endonuclease activity similar but not identical to APE1. EEPD1 can replace APE1 in BER assays in vitro and in
vivo. EEPD1 depletion also harmed the repair and restart of oxidatively damaged replication forks. EEPD1
depletion or deletion also resulted in significantly decreased cell survival in the presence of oxidative or
alkylative stressors, which cause DNA lesions repaired by BER. EEPD1 has a high differential expression in
glioblastoma (GBM) compared to adjacent normal brain or other cancers. GBM exist in a hypoxic environment
and are sensitive to oxidative injury, and EEPD1 is required for the survival in every GBM cell line tested. Our
SEC-MALS studies found that EEPD1 exists as a dimer in physiologic solution. We resolved the X-ray
crystallographic structure of the EEPD1 nuclease domain to 3.0 Å. The tertiary structure of the EEPD1
monomer is similar to the AlphFold2-predicted EEPD1 nuclease domain structure. The EEPD1 crystal
structure also has similarities to and distinctions from the APE1 structure. Thus, EEPD1 represents a unique
opportunity to gain insight into the structural basis for abasic endonuclease activity and how this activity
promotes repair of oxidatively-stressed replication forks. Understanding the structure-function relationship of
EEPD1 will lead to regions to target for development of rationally designed inhibitors, for which we have
candidate compounds. This is especially important in GBM, for which new therapeutic targets are sorely
needed. This renewal application will assess how the structure of EEPD1 functions to repair of replication forks
stressed by oxidative DNA damage in GBM cells by addressing three questions: 1) Is EEPD1 dimerization
essential for its activity? 2) What EEPD1 domains mediate its 5’ abasic endonuclease activity? 3) What
are the distinct roles for EEPD1 versus APE1?

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Just by using oxygen to generate energy, cells sustain daily oxidative DNA damage. This oxidative DNA damage is especially dangerous at replication forks, where the damage must be repaired before replication makes the oxidative mutations permanent. EEPD1 mediates a unique pathway for the cell to repair this damage that brain cancers subvert for their survival.